Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core will be based in the Department of Molecular Biology and Microbiology at the Tufts
University School of Medicine and will provide managerial and organizational support related to the proposed
Program Project. The Administrative Core leader, Dr. Linden Hu, who is also the overall project PI, will provide
scientific leadership, facilitate communication among all members of the P01, arrange for evaluation by a
Scientific Advisory Board, manage the financial aspects of the program, and assure compliance with Federal
regulations. In addition, the Administrative Core will be responsible for overseeing the dissemination of
information produced by the project to the broader scientific community and the public. Dr. Hu will be
supported in the Administrative Core by the Executive Committee that will be comprised of the Project and
Core Leaders, Dr. Robert Smith, Dr. Sam Telford, Dr. John Leong, Dr. John Branda and Dr. Allen Steere. All
of these investigators are highly respected leaders in the field of Lyme disease with a long track record of
scientific discovery and management experience. The Executive Committee shall provide overall scientific
guidance and lead future directions for the Program Project based on constant exchange of data and
information.
To meet the goals listed above, the Administrative Core has the following Specific Aims: 1). Establish
leadership and management plans for oversight of the four projects and scientific core; 2). Create a
communication and dissemination plan to maximize synergies between the projects and scientific core; 3).
Coordinate the Evaluation and Progress Report process. Each of these aims will be developed with a focus on
improving coordination and interaction between the Cores and the Projects, facilitating exchange of information
and advancing knowledge and resources for the scientific community and the public so as to improve the
management of Lyme disease.

Public health relevance
NARRATIVE: ADMINISTRATIVE CORE Crucial to any complex clinical study is coordination of all of the different parts of the team that need to function together to make the project a success. The Administrative Core will be in charge of overseeing the functioning of the project and ensuring that the different parts work well together and are communicating with each other. Communication between members of the Project as well as from the Project to the Public will use multiple different avenues including but not limited to regularly scheduled meetings/retreats, shared communication channels (e.g. Slack and group elists), social media and creation of a website.